Achieving successful treatment outcomes among adolescents and pregnant/postpartum women living with HIV in Kenya

Project Summary
Overview: This K24 mid-career investigator award in patient-oriented research and mentorship proposes to
expand the research and mentorship activities of a highly qualified candidate, Dr. Lisa Abuogi, focused on
improving HIV and health outcomes for people living with HIV in high burden, low resource settings.
Candidate: Dr. Abuogi is a physician-scientist trained in pediatrics, global health, and HIV and an Associate
Professor at the University of Colorado Denver (UCD). She is also a Senior Investigator in the UCD Center for
Global Health and Medical Director of the Children's Hospital HIV Prevention Program. Dr. Abuogi conducts
patient-oriented research to address disparities in HIV health outcomes, including retention in care and viral
suppression, among pregnant women, adolescents and children living with HIV. She has a sustained track record
of extramural funding and demonstrated dedication to successful mentorship of new investigators.
Mentoring Plan: Dr. Abuogi has a demonstrated commitment to highly successful mentorship of a diverse group
of mentees. She has the ability to recruit multidisciplinary mentees from a wide range of research collaborations
and networks, a structured approach to ensure high quality mentorship, and a commitment to build the next
generation of investigators committed to research aimed addressing knowledge gaps and at improving HIV
outcomes.
Research Plan: Dr. Abuogi's proposed research activities address NIH's Office of AIDS Research Priority
Research agenda in Cross Cutting research that includes implementation and behavioral sciences, health
disparities, and training and capacity building. Leveraging her ongoing NIH-funded research evaluating
behavioral interventions to improve HIV care outcomes for both pregnant/postpartum
and
on
1,
viral
women and adolescents
young adults living with HIV (AYA), Dr. Abuogi proposes innovative new patient-oriented research focused
the sustainable impact f interventions aimed a improving engagement in care and viral suppression. In Aim
Dr. Abuogi will examine the effect of short-term peer navigation on long-term sustained re-engagement and
suppression in AYA on antiretroviral treatment after navigation is discontinued. In Aim 2,
o t
determine the
impact of behavioral interventions on care transitions in these populations. Finally, in Aim 3, she will explore the
perceptions of patients and LHW on how the interventions support treatment success as well as unintended
consequences of peer-led interventions to inform iterative adaptations of these interventions.
proposed
evidence-based
provide
The newly
research described in this application will expand our understanding of the sustainable impact of
interventions aimed at improving treatment outcomes for vulnerable populations with HIV and
research opportunities for new mentees.

Public health relevance
Project Narrative Dr. Abuogi has extensive experience conducting interdisciplinary implementation science research that addresses key knowledge and outcome gaps for women, adolescents and children living with HIV. Dr. Abuogi has a demonstrated commitment to training new investigators and a track record of mentorship success and productivity. This award provides her with protected time to expand her mentoring and research activities related to improving HIV and health outcomes for vulnerable populations living with HIV in high burden settings.